External Research Resources Support and Dissemination Core

The statistical Data Enclave Core will support the growing need for methods that allow the distribution of useful public data that maintains confidentiality of study subjects. Specifically, this Core focuses on facilitating the use of data that is currently subject to various forms of confidentiality restrictions, thus increasing access to large-scale databases with complex phenotypes that are linked to administrative data, small area geographic data and biological and genetic data. A primary objective of the center is the development and application of leading-edge mathematical and statistical models for data masking for demographic datasets on aging.

Public health relevance
By developing new research areas, by supporting and enlarging the world's community of demographic scientists, and by developing new mathematical and statistical methods for the analysis of data related to the biodemography of aging as well as data management services, CPHA will advance understanding of the determinants of health, aging, and longevity.